NERO Annual Conference & Training Seminar 2021 - 2025

National Egg Regulatory Officials Annual Conference & Training Seminar
Project Summary
The National Egg Regulatory Officials (NERO) submits this proposal to the Food And Drug
Administration under the Support of Small Scientific Conferences Grant Program. Grant
assistance will be used to develop and conduct a three day conference and training seminar
entitled "National Egg Regulatory Officials' Annual Conference and Training
Seminar". NERO's long term objective is to increase conference attendance so that all
fifty states and the District of Columbia are represented at the annual conference. Many
states do not have travel funding to attend the Annual Conference and Training Seminar.
Grant assistance will enable more states to attend the Conference. The project will assist
NERO with the 2021 conference as well as our 2022, 2023, 20243 and 2025 conference.
NERO's mission is to promote the marketing of safe, fresh and accurately labeled shell eggs
and egg products through the development of uniform, science-based and coordinated
state and Federal regulations. The Annual Conference and Training Seminar is designed to
achieve this goal by providing educational segments related to current egg safety and
quality issues and the opportuntity for state, Federal and industry representatives to
intereact and share scientific data, public policies and ideas. A key feature of the
conference is the presentation of information related to specific issues that is then referred
to NERO's Committees comprised of specialists in that area. The committees review the
information and develop specific recommendations for the most effective and cost efficient
method of achieving the desired result. NERO members use these recommendations to
implement regulations and policies.
The conference for which support is being sought will specifically address FDA Egg Rule,
new technologies, food safety issues related to small flock egg production, labeling and
data management, as well as the newly reviewed Egg Regulatory Program Standards.
Respresentation of every state at the annual conference and training seminar is critical to
achieve NERO's goal of uniform, science-based and coordinated state and Federal
regulations and policies in these areas. Funding for this grant proposal will increase the
number of states represented at the Annual Conference and Training Seminar.

Public health relevance
National Egg Regulatory Officials Annual Conference & Training Seminar Project Narrative Grant funds assistance will be used to develop and conduct a three-day conference and training seminar that will provide a forum for stakeholders to share information and promote integration through collaboration. Grant funds will also assist state members that do not have travel funding to attend the Annual Conference & Training Seminar.